Epigenomic cell-type classification and regulatory element identification in the human brain

Abstract Understanding the exact cell-­type composition in the different regions of the human brain is a fundamental step when trying to integrate physiological, behavioral, neurochemical and molecular data. At present, although major categories of cell-­types present in the human brain have been defined through a handful of specific markers, the different subtypes within these categories as well as their location are far from understood. Cytosine DNA methylation (mC) is a stable epigenomic signature that persists in post-­mitotic cells throughout their lifetime, defining their cellular identity. Open chromatin marks gene regulatory elements that control cell type-­specific gene expression patterns. Single cell DNA methylation and open chromatin profiles have been successfully used to identify de novo distinct cell types in heterogeneous tissues including the brain. This U01 aims to produce a first version of an epigenomic cell atlas at the single-­cell level across the human brain. Multi-­modal integration between epigenomic and transcriptomic signatures will allow the identification of new cell types and unique cell-­type markers that will become available to the community. Epigenomic profiling of human brain cells permits the discovery of cell type-­specific regulatory regions, which will facilitate the functional analysis of genetic variants associated with psychiatric and neurological disorders.

Public health relevance
PROJECT NARRATIVE Brain function arises from networks of cells connected to each other in neural circuits. The goal of this U01 project is to understand the identity of the many different kinds of cells in various regions of the human brain. Determining the cell composition of the human brain will aid in the understanding of a variety of human diseases such as schizophrenia or autism where these neural circuits may be abnormal.